OUTCOME OF DAY HOSPITALIZATION FOR SEVERELY ASTHMATIC CHILDREN

This was a pilot study in which the primary purpose is to explore physiological patterns of stress rectivity among asthmatic children. Recent findings from this laboratory show that patterns of cardiac reactivity are different for asthmatic than for healthy children, and for allergic and nonallergic children. Psychological difficulities are also more common among asthmatic children than among healthy children and increase in prevalence with greater asthma severity.